Quantifying peripheral blood antigen-specific memory B cells as a new biomarker in patients with PLA2R-associated membranous nephropathy

Quantifying peripheral blood antigen-specific memory B cells as a new biomarker in patients with
PLA2R-associated membranous nephropathy
Primary membranous nephropathy (PMN) is the most common cause of nephrotic syndrome in nondiabetic
adults. The dominant autoantigen, phospholipase A2 receptor (PLA2R), is associated with 70~80% of clinical
cases. B-cell depletion therapies such as Rituximab have now become the first-line treatment option for PMN.
Although effective, Rituximab (alone or combined with Calcineurin inhibitors) has an overall failure rate of 30-
35%, raising controversies on the ideal dosage and best treatment protocol. Monitoring circulating CD20+ B-cell
recovery is instrumental in guiding Rituximab therapy; however, it provides little value in predicting the treatment
outcome. None of the current diagnostic tests, including measuring proteinuria, serum creatinine, glomerular
filtration rate, and antibody titers by ELISA test, nor kidney biopsy, can predict a patient’s response to
immunosuppressive therapies and disease progression. We developed a flow cytometry-based assay that
detects and quantifies circulating PLA2R antigen-specific memory B cells (PLA2R-MBCs), the precursor of anti-
PLA2R autoantibody production, in PMN patients. We applied the test to 94 human subjects, including a
retrospective longitudinal study of 19 patients with PLA2R-MN followed over 2 to 12 years. We observed that
the levels of circulating PLA2R-MBCs are associated with the disease status and could provide crucial
immunological information not captured by the PLA2R-Ab ELISA and other biomarker tests, which could help to
1) assess patient response to immunosuppressive therapies for optimal dosages and courses for the best
treatment outcome, and 2) monitor the earliest sign of disease relapse for early treatment intervention to preserve
kidney functions. Building upon these promising initial clinical observations, we propose to develop the assay
into a test kit for future extensive cohort studies. We envision the test will enable nephrologists for the first time
to customize treatments for individual patients to achieve the best treatment outcome with minimal side effects,
significantly reducing the social and financial burden on the US healthcare system and driving down the Medicare
spending for this group of patients.

Public health relevance
Project Narrative The proposed project focuses on developing a proprietary biomarker assay into a clinical test kit to assist nephrologists in designing customized treatments for individual patients with primary membranous nephropathy (PMN) to achieve the best treatment outcome and preserve kidney functions. PMN is the most common cause of nephrotic syndrome in nondiabetic adults, and the second leading cause of kidney failure among glomerulonephritis.